Molecular determinants of axonal RNA translation

Localization of mRNAs with subsequent translation into new proteins provides a means to geographically regulate neuronal protein composition in distinct subcellular regions. In axons, this localized protein synthesis is needed for growth cone guidance and regeneration. Although mature axons show little evidence for localized protein synthesis, injury appears to increase the neuron's ability to locally generate new axonal proteins. We suspect that injury invokes a fundamental change in how the neuron targets mRNAs into and translates mRNAs within axons. Locally synthesizing proteins at sites distal from the neuronal perikaryon requires a coordinated effort to package and target mRNAs and translational machinery for delivery to the correct locale. In large part, this targeting is accomplished through specific RNA-protein interactions. For axonal mRNA transport and translation, exceptionally little is known of which mRNA elements are needed for this RNA-protein interaction and which RNA binding proteins are targeted into axons. Here we propose to dissect the molecular determinants for targeting mRNAs into axons. In the first aim, we will determine the localizing elements of axonal mRNAs that are regulated at the level of transport, translation, or both using PNS sensory neurons. In the second aim, we will test functionality of these RNA localization elements in CNS neurons that show complete axonal-dendritic polarization. Finally, we will generate and characterize viral reporter constructs that will enable us to address RNA localization mechanisms in vivo.

Public health relevance
Despite works showing that injury can condition neurons for enhanced axonal regeneration including growth into the normally non-permissive environment of the brain and spinal cord, we have little knowledge of the downstream targets that support this enhanced regenerative capacity. Discovering those downstream targets will give us new strategies for enhancing neural repair. Over the previous funding period, we discovered that proteins are locally synthesized in regenerating axons. Several lines of evidence indicate that this localized protein synthesis facilitates regenerative responses. The objective of the current proposal is to dissect the mechanisms used to localize templates for protein synthesis into injured nerves and develop tools to test these mechanisms in vivo.